MEASURING UREAGENESIS IN PATIENTS WITH OTC DEFICIENCY

The purpose of this study is to measure changes in ureagenesis after gene therapy in patients with OTC deficiency, an inborn error of urea synthesis. Current treatment is unsatisfactory. A Phase I study of adenoviral mediated gene therapy is underway. We are a collaborating insititution and wish to 1) perform heavy isotope/allopurinol studies to measure efficacy of the experimental treatment; and 2) to obtain blood for liver, renal, hematologic, and immune function to study safety.